Image Analysis of Neurofacial Effects of Prenatal AlcoholExposure

Abstract As a constitutent component of CIFASD4, this project will focus on earlier detection of the neurofacial effects of prenatal alcohol exposure. Four topics of the Request for Application (RFA) will be targeted: a) improved FAS/FASD facial recognition through 3D photography and computer analyses in individuals of different age groups; b) the utility of prenatal ultrasound as a screening or diagnostic modality; c) 3D facial imaging during the neonatal period to detect more subtle facial features affected by prenatal alcohol exposure; d) innovative uses of technologies, including handheld devices with apps, to screen for dysmorphology. Previously, we have implemented methods and associated software for analyzing postnatal face shape for the detection of the effects of prenatal alcohol exposure. Although effective in their accuracy, they rely on the use of expensive and relatively clumsy 3D cameras for which not insignificant training is required. New methods of 2D image analysis are available, mobile device acquisition of 3D images is imminent and online recruitment to clinical research is becoming more common place. Finally, state-of-the-art machine learning methods are proving effective in large-scale analysis of ultrasound and MRI data. To accomplish our goals, we propose the following specific aims: 1. Automated screening of facial images for effects of prenatal alcohol exposure with potential for on-line and mobile device use and integration of genetic, behavioral and cognitive data; 2. Fetal ultrasound analysis to detect facial, cranial and neural effects of prenatal alcohol exposure with neonatal follow-up; 3. Algorithm and software development to improve current analysis of face-brain-alcohol interactions. Achieving aim 1 will dramatically impact access to validated facial screening for prenatal alcohol exposure. Successful demonstration of aim 2 will achieve the earliest possible diagnosis enabling further research on interventions but also anticipatory neonatal management. Progress in aim 3 will enhance face-brain morphometric analyses in collaboration with other CIFASD partners (U01:Parnell/Eberhart, U01:Wozniak). We will work collaboratively with consortium partners who will recruit subjects and provide facial and ultrasound images (U01: Chambers; U01: Coles; U01: Mattson; U01: Weinberg; U01: Wozniak). We will co- operate on the analysis of images arising from basic science partners focusing on the use of animal models. We will rely on research resources for validation of postnatal screening tools (R24 Dysmorphology - Jones) and online/app development and data management (R24 Informatics - Barnett).

Public health relevance
Project Narrative The goal of this project is to develop new methods for screening for the effects of prenatal alcohol exposure. It will exploit the wide availability and convenience of smartphone and tablet devices to detect the facial effects in children and adults and new ways of analyzing ultrasound images to detect facial and brain effects in the fetus. Our aim is to establish earlier detection so as to allow earlier intervention to improve outcome.